A Tailored mHealth Vaping Prevention Intervention for Adolescents with Congenital Heart Defects

PROJECT SUMMARY/ABSTRACT: Congenital heart defects (CHD) affect over 2.4 million individuals in the
U.S and generate $6.1 billion in annual healthcare costs. Avoidance of tobacco is vital to mitigate CHD
survivors’ risk for acquired cardiovascular complications, but the youth e-cigarette (“vaping”) crisis exposes the
growing and vulnerable population of adolescents (“teens”) with CHD to potential vaping-related harms and
significantly increases risk for conventional cigarette use. Interventions to prevent vaping among teens with
CHD are critically needed, but no existing programs are sufficient for this at-risk group. Dr. Fox’s TL1
fellowship research showed that 31% of teens with CHD are susceptible to vaping and identified perceived
stress and poor disease knowledge as potential risk factors, but existing programs do not address these
considerations. The proposed research will generate and evaluate the first vaping prevention intervention
tailored for teens with CHD. Aim 1: Adapt curriculum from an evidence-based, classroom-delivered vaping
prevention intervention to include critical stress management and disease knowledge modules in a mobile
Health (mHealth) format for teens (12-18 years) with CHD. Intervention adaptation/refinement will occur via: 1)
focus groups with key stakeholders (teens with CHD, parents, cardiologists) to understand intervention
preferences, and 2) a single-arm pilot trial of the adapted mHealth intervention (N=16) with follow-up focus
groups to gather information for refinement. Aim 2: Evaluate the feasibility/acceptability of the mHealth
intervention via a pilot randomized clinical trial (RCT; N=72). Exploratory Aim 3: Explore the preliminary
efficacy of the mHealth intervention for indicators of vaping prevention (vaping-related efficacy, perceived
vaping outcomes, e-cigarette knowledge). These aims directly align with Dr. Fox’s career goal of becoming an
independent clinician-scientist with expertise in behavioral RCTs and scalable disease self-management
interventions for transition-aged teens with CHD. To achieve this goal, Dr. Fox requires advanced training in
the following areas: 1) behavioral intervention science to design and optimize interventions that can be
implemented on a public health level, such as mHealth modalities, 2) RCT methodology and analysis to
rigorously evaluate behavioral interventions for efficacy and effectiveness, and 3) CHD disease self-
management and healthcare for transition-aged teens to incorporate unique factors of living with CHD into
tailored interventions. The career development plan involves didactic and applied training and leverages expert
multidisciplinary (public health, clinical/quantitative psychology, cardiology) mentorship from The Abigail
Wexner Research Institute at Nationwide Children’s Hospital, one of the worlds’ fastest growing pediatric
research centers, its academic affiliate The Ohio State University, and the Fred Hutchinson Cancer Research
Center. This K23 proposal will provide high-quality preliminary data and instill expertise needed for an R01
efficacy trial, advancing toward the ultimate goal of enhancing wellbeing across the lifespan of CHD.

Public health relevance
PROJECT NARRATIVE Congenital heart defects (CHD) are responsible for $6.1 billion dollars in annual healthcare costs, primarily due to acquired cardiovascular complications. Prevention of tobacco use (e.g., e-cigarettes [“vaping”], combustible cigarettes) is critical for the long-term wellbeing of adolescents with CHD, but there are no interventions to prevent vaping among this vulnerable group. This research will adapt and evaluate the first vaping prevention intervention tailored to adolescents with CHD, which may ultimately contribute to enhanced health and wellbeing for CHD survivors.